INTERACTORS OF MYC ASSOCIATED ZINC FINGER PROTEIN (MAZ)

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. We have affinity purified MAZ from HeLa cells and analyzed the copurifying proteins by Maldi MS. The only protein identified was keratin. The experiment was repeated paying special care not to contaminate the sample with exogenous keratin. Again, the only protein identified was keratin. Keratin was only identified in the ~60 kDa gel lane (endogenous?). In addition, the control lane of a 1D SDS page gel did not differ significantly from the IP lane. The only visible difference was identified as MAZ. This could either be a degradation product or an alternative splicing product of full length MAZ. We continue to optimize the sample purification conditions.